Role of Tick Metalloprotease Inhibitors in the Transmission of Borrelia burgdorferi

Project summary. This project aims to characterize the previously unstudied roles of tick inhibitors of
metalloproteases, a class of proteases requiring metal cofactors, in the transmission of the Lyme disease agent
by blacklegged nymphal ticks. This goal is based on evidence that these proteases are among the largest class
of innate immunity effector proteases in the skin, which ticks must block to feed and transmit tick-borne disease
agents. Preliminary findings demonstrate that these candidate proteins are functional and that their mRNA
expression significantly increases in blacklegged ticks infected with the Lyme disease agent, suggesting that
these proteins may play roles in the transmission of the disease. The overarching hypothesis is that ticks inject
these candidate proteins to suppress the functions of metalloproteases, allowing them to complete feeding and
transmit tick-borne disease agents. This hypothesis will be tested in two specific aims, starting with unveiling the
protease inhibition profiles of putative tick inhibitors of metalloproteases in skin and plasma using protein-to-
protein interaction assays to identify key anti-tick innate immunity proteins that are blocked by candidate proteins.
The second specific aim will involve elucidating the roles of tick inhibitors of metalloproteases in Lyme disease
agent transmission using RNA interference technology in a mouse model to knock down the target protein's
mRNA. Successful completion of this project will provide novel insights into how blacklegged nymphal ticks utilize
tick inhibitors of metalloproteases to evade skin immunity and lay the groundwork for the development of a tick-
antigen-based vaccine to prevent Lyme disease. This application responds to notices of special interest related
to immune responses to arthropod feeding (NOT-AI-21-059) and advancing research for tick-borne diseases
(NOT-AI-23-013).

Public health relevance
Project Narrative. Advancing innovative technologies to combat tick-borne diseases hinges on a thorough understanding the functions of important tick proteins that facilitate transmission of the Lyme disease agent. This proposal aims to elucidate the roles of tick inhibitors of metalloproteases in the transmission of the Lyme disease agent. Our goal is to provide insights into the intricate interactions at play, shedding light on the specific ways these proteins contribute to the success of the Lyme disease agent in establishing infection.